Targeting myofibroblast activation in chronic fibrotic disease

Principal Investigator/Program Director (Last, first, middle): Strauch, Arthur, Roger RESEARCH &RELATED Other Project Information 1. * Are Human Subjects Involved? m Yes l No 1.a. If YES to Human Subjects Is the IRB review Pending? m Yes m No IRB Approval Date: Exemption Number: 1 2 3 4 5 6 Human Subject Assurance Number 2. * Are Vertebrate Animals Used? l Yes m No 2.a. If YES to Vertebrate Animals Is the IACUC review Pending? m Yes l No IACUC Approval Date: 12-18-2006 Animal Welfare Assurance Number A3261-01 3. * Is proprietary/privileged information m Yes l No included in the application? 4.a.* Does this project have an actual or potential impact on m Yes l No the environment? 4.b. If yes, please explain: 4.c. If this project has an actual or potential impact on the environment, has an exemption been authorized or an environmental assessment (EA) or environmental impact statement (EIS) been performed? m Yes m No 4.d. If yes, please explain: 5.a.* Does this project involve activities outside the U.S. or m Yes l No partnership with International Collaborators? 5.b. If yes, identify countries: 5.c. Optional Explanation: 6. * Project Summary/Abstract Abstract1001405880.pdf Mime Type: application/pdf 7. * Project Narrative ProjectNarrative1001405881.pdf Mime Type: application/pdf 8. Bibliography &References Cited Bibliography1001406320.pdf Mime Type: application/pdf 9. Facilities &Other Resources Facilities1001405883.pdf Mime Type: application/pdf 10. Equipment Equipment1001405884.pdf Mime Type: application/pdf Tracking Number: Other Information Page 5 OMB Number: 4040-0001 Expiration Date: 04/30/2008 Principal Investigator/Program Director (Last, first, middle): Strauch, Arthur, Roger 6. PROJECT SUMMARY/ABSTRACT Chronic accumulation of myofibroblasts in healing wounds is associated with hypercontractility, excessive deposition of interstitial collagens, and destructive tissue remodeling. Vascular smooth muscle alpha-actin (SMaA) is a contractile protein transiently expressed by differentiated myofibroblasts for generating tensile force required to close open wounds. In chronic fibrotic disease, myofibroblast differentiation is dysfunctional and we discovered that molecular signaling required for activation of both the SMaA and type I collagen genes in these cells also provides negative feedback that could potentially limit the recruitment of hyperactive myofibroblasts during wound healing and destructive remodeling. Studies outlined in this proposal are expected to reveal novel forms of functional interplay of the DNA- and mRNA-binding proteins YB-1, Pur alpha, and Pur beta with the SMaA and type I collagen promoters and clarify how these proteins are affected by pro- fibrotic agents such as TGFb1 and thrombin that, if unchecked, may cause myofibroblast progression to hypertrophic scarring. Experiments are designed to initiate, amplify, or attenuate myofibroblast differentiation to better understand strategies for controlling SMaA and type I collagen gene output at the transcriptional and translation levels as well as reveal novel interventional strategies that might be useful for minimizing aberrant wound healing outcomes. Aim 1 will examine TGFb1-regulated interaction of YB-1 and Pur protein repressors with SMaA and collagen promoter DNA and the transcriptional activators Sp1, SRF, and Smads 2,3, delineate regions of repressor polypeptide chains required for this functional interplay, and attempt to disrupt complex formation and disable pathobiologic myofibroblast differentiation using peptide decoys and small molecule pharmacologic inhibitors. Aim 2 will determine if thrombin potentiates myofibroblast differentiation at the level of translational control thus functioning as a TGFb1 supplement or instead antagonizes this growth factor by blocking transcription and myofibroblast recruitment by inducing the anti-fibrotic transcriptional regulatory protein, Egr-1. Aim 3 studies will explore alternative, Smad-independent mechanisms of myofibroblast differentiation and fibrosis. Loss-of-function approaches based on pharmacologic inhibition of TGFb1/Smad kinase- or phosphatidylinositol-3-kinase(PI3K)/Akt kinase signaling will be used to evaluate their possible suppressive effect on myofibroblast activation in vitro and cardiac fibrosis in mice after ischemia/reperfusion injury. The ability of TGFb1 and thrombin to exploit the unique DNA-, RNA-, and protein-binding properties of YB-1 and Pur proteins adds a new dynamic perspective to control of gene expression during myofibroblast differentiation that may reveal optimum strategies for therapeutic management of chronic fibrotic diseases. Project Description Page 6

Public health relevance
Project Narrative: The proposed research investigates cellular and molecular changes in connective tissue cells in heart and lung tissues that are required for normal wound healing after surgery. In transplant patients as well as individuals diagnosed with various forms of chronic cardiopulmonary diseases, these processes are accelerated leading to permanent scar formation, structural deformities in the heart and lung, loss of tissue function, and early death. New research studies outlined in this application will examine the individual biochemical pathways that drive normal wound healing and attempt to identify new targets for drug therapy that will help control destructive wound healing activity and improve the quality of life for individuals suffering from chronic diseases that cause abnormal scar tissue formation in the heart and lung.